Understanding the role of tether proteins to maintain chromatin-nuclear lamina contacts in premature aging.

Project Summary/Abstract
This proposal outlines an investigation into the role of chromatin-tethering proteins in maintenance of peripheral
heterochromatin and the integrity of nuclear lamina. It is well established that heterochromatin association with
the nuclear lamina plays an important role in development, and contributes to maintenance of the adopted cell
fate. Genetic mutations in lamina proteins, such as is seen in Hutchinson-Gilford progeria syndrome (HGPS), is
associated with alterations in the morphology of the nuclear lamina and disruption of peripheral heterochromatin.
However, the precise link between nuclear lamina mutations and heterochromatin positioning remains unclear.
I propose to test if the chromatin-tethering protein PRR14 plays a critical role in this process and therefore
functions in the premature aging pathway. Our data demonstrate that PRR14 organizes a significant fraction of
heterochromatin at the nuclear lamina. Lack of PRR14 results in detachment of the peripheral heterochromatin
from the nuclear lamina, while PRR14 overexpression substantially increases the fraction of heterochromatin
located at the nuclear periphery. Previous findings implicate PRR14 as an epigenetic repressor and its loss can
release transcriptional gene silencing. Furthermore, our results demonstrate that PRR14 loss results in nuclear
lamina defects similar to those observed in diseases associated with nuclear lamina mutations. Here we propose
to study the role of PRR14 in maintenance of chromatin organization at the nuclear lamina and assess how
nuclear lamina mutations act through PRR14 to cause dysregulation of lamina-associated chromatin. We will
determine the effect of PRR14 loss on heterochromatin organization at the nuclear lamina and define epigenetic
features that mark genome regions for nuclear lamina localization via PRR14. Further, we will determine how
nuclear lamina mutations affect the PRR14 function in organizing chromatin at the nuclear lamina by testing how
Progerin (a mutant form of Lamin A protein) affects the PRR14-nuclear lamina interaction and triggers nuclear
lamina and peripheral heterochromatin defects. Finally, to determine if PRR14-nuclear lamina association is
affected by farnesyl group modification on Progerin, we will test whether farnesyltransferase inhibitors restore
PRR14 function in tethering heterochromatin in HGPS cells. Our work will provide critical insights into the
fundamental knowledge of chromatin association with the nuclear lamina. This would significantly advance our
understanding of molecular mechanism behind nuclear lamina and genome organization defects observed in
laminopathy diseases.

Public health relevance
Project Narrative This project aims understand the role of chromatin-tethering proteins in organizing the genome at the nuclear lamina. Emerging data suggest that chromatin organization at the nuclear lamina is a critical mechanism of epigenetic regulation of the genome, instabilities of which lead to premature aging, some forms of heart failure and tumorigenesis. Understanding how chromatin is tethered to the nuclear lamina will advance our understanding of the molecular mechanisms underlying the cause of these diseases, while also adding to our fundamental knowledge of spatial genome organization in the nucleus.